Characterizing IgA-microbe interactions in type 1 diabetes

PROJECT SUMMARY
Type 1 diabetes (T1D) is a chronic autoimmune disease that often emerges during childhood due to T cell-
mediated destruction of insulin-producing  cells in the pancreas. Over the last 30 years, the incidence of T1D
has increased by 3-4%, a rapid change that cannot be explained by genetics alone. Diverse environmental
factors including the microbiota have been associated with the increased incidence of T1D, but the mechanisms
by which the microbiota influences T1D pathogenesis are not well understood. Studies of non-obese diabetic
(NOD) mice and human patients with T1D have similarly revealed associations between protection against T1D
and the relative abundance of Akkermansia muciniphila (A.M.) in the gut. A.M. is a Gram-negative, mucin-
degrading obligate anaerobe that exerts beneficial effects on the host gut such as increasing mucus production,
goblet cells, antimicrobial peptides, and tight junction proteins. These potentially beneficial immunomodulatory
effects of A.M. are exciting, but the immune-microbe interactions that mediate these effects are not fully
understood. A.M. is also a potent inducer of secretory IgA (sIgA), which plays important roles in modulating
microbial colonization and altering microbial gene expression. Small intestinal Peyer’s Patches (PP) are key
sites at which B cells respond to the microbiota. There, B cells undergo class switching, somatic hypermutation,
and affinity maturation, resulting in the downstream production of high affinity sIgA. How autoimmunity impacts
sIgA production and subsequent sIgA-microbe interactions is not known. To address this gap, I will modulate B
cell signaling via the genetic deletion of Bruton’s tyrosine kinase (Btk), a B cell signaling protein. We previously
discovered that genetic depletion of Btk selectively eliminates autoreactive B cells, thereby preventing T1D in
NOD mice. However, this phenotype is dependent on the composition of the microbiota. Monocolonization of
germ free Btk-deficient mice with A.M. alone confers protection against T1D. In this setting, WT NOD mice have
decreased A.M. abundance compared to Btk-deficient NOD mice. We hypothesize that Btk-deficiency protects
against T1D in NOD mice by interfering with the production of sIgA that would prevent A.M. colonization.
Accordingly, we seek to identify WT NOD derived IgA that binds A.M. and promotes its clearance from the gut.
We will first define the contributions of BTK-mediated B cell receptor (BCR) signaling to the PP B cell repertoire.
Then, we will produce monoclonal IgA from PP B cells from monocolonized mice and evaluate the functionality
of this A.M.-induced sIgA. We will test the ability of this IgA to modulate A.M. in vitro and create monoclonal
antibodies (mIgA) hypothesized to reduce A.M. abundance in vivo. Finally, we will test whether supplementation
with mIgA reduces A.M. abundance and causes an increase in T1D in Btk-deficient NOD mice monocolonized
with A.M. This work will support a new paradigm by which BTK-mediated B cell signaling modulates the
microbiota, with downstream effects on T1D pathogenesis.

Public health relevance
PROJECT NARRATIVE How the microbiota contribute to type 1 diabetes (T1D) pathogenesis is not well understood, though the increased relative abundance of Akkermansia muciniphila (A.M.) is associated with protection against T1D in both mouse models and patients. In this proposal, we aim to determine how B cell signaling contributes to mucosal immunity, with the goal of understanding the role of IgA-A.M. interactions in T1D. Ultimately, these findings will generate new knowledge of immune-microbial crosstalk and potentially create therapeutic opportunities to prevent the onset of T1D.